TRIAL OF ESCALATING DOSE PACLITAXEL IN PATIENT WITH REFRACTORY SOLID TUMORS

ACTG 291 - The purpose of this research study is to determine the maximum dose of 96 hour paclitaxel infusion that can be tolerated by patients when given with growth factor (G-CSF).